Defining the Mechanisms and Consequences of Nuclear Defects in ALS/FTD

PROJECT SUMMARY
A detailed insight into the molecular defects leading to neuronal death in ALS/FTD is still missing, hindering the
development of a cure. Defects in the nuclear pore complex (NPC) and nucleocytoplasmic transport (NCT)
have been proposed to play a central role in ALS/FTD pathology. An outstanding knowledge gap is what are
the mechanisms, consequences, and pathogenic relevance of impaired NCT on neuronal resilience in
neurodegenerative diseases and during aging. The objective of this application is to identify at the mechanistic
level the novel cellular and molecular pathways that are dysfunctional and cause the failure of the NCT
ultimately leading to neurodegeneration. In particular, we will test the hypothesis that the actin cytoskeleton is a
main modulator of nuclear stability and NPC function, and that changes to this pathway in ALS/FTD lead to a
diminished ability of neurons to cope with stress and physiological stimulation.
The specific aims of this proposal are to: 1) Define how actin regulates the function and dysfunction of the
NPC. We will perform a systematic and in-depth investigation of the molecular interactions between actin and
the NPC using pharmacological and genetic approaches in iPSC-derived neurons carrying the C9ORF72
mutation. 2) Identify the consequences of NCT defects on the nuclear and cytoplasmic proteome in
response to cellular stimulation. By combining an “omics” approach with a candidate approach (i.e. CREB
pathway), we will analyze changes in the nuclear and cytoplasmic proteome in iPSC-derived neuronal models
of ALS/FTD following stimulations, and we will test the potentials of cytoskeleton modulation to rescue such
defects. 3) Define how defects in nuclear import affect the transcriptional response to cellular
stimulation. We will analyze changes in gene expression and splicing profile in ALS/FTD neurons following
cell stimulation by RNA-Seq. Network analysis performed by integrating the results from the transcriptomic and
proteomics approaches will identify ALS/FTD relevant altered pathways. Modulation of the cytoskeleton will be
used to rescue the identified defects.
At the completion of this research, we will have identified the molecular and cellular mechanisms that control
the stability and function of the NPC, and the functional consequences that the disruption of NCT has on the
resilience of neurons in ALS/FTD. Gaining insights on what pathways upstream and downstream of the NPC
are affected in ALS/FTD will greatly expand our understanding of disease pathogenesis and will allow us to
identify yet unexplored avenues for therapy in these diseases. Ultimately, we expect that our research will lead
to more effective therapeutic strategies that take advantage of the crosstalk between NPC, RNA regulation,
and cytoskeleton. This research will have a broad impact on a spectrum of diseases including but not limited to
ALS/FTD.

Public health relevance
PROJECT NARRATIVE Neurodegenerative diseases such as ALS/FTD represent an outsized burden to a progressively aging world population, and no cure exists to alleviate symptoms or stop the progression of these diseases. The proposed research is expected to elucidate at the mechanistic level the novel molecular pathways underlying cellular pathology in human ALS/FTD neurons. We anticipate that this research will contribute to the identification of novel targets in these pathways for the development of innovative therapeutic strategies for ALS/FTD and potentially other neurodegenerative diseases.